Molecular Basis of Gene Regulation by Polycomb Repressive Complex 2

Project Summary:
Polycomb Repressive Complex 2 (PRC2) maintains an epigenetic memory of cell identity and controls
many fundamental cellular processes, such as stem cell pluripotency maintenance, stem cell differentiation, X-
chromosome inactivation, imprinting, and so on. Dysregulation of PRC2 function is associated with a wide
spectrum of cancers and developmental disorders. On the molecular level, PRC2 mediates histone H3 lysine
27 trimethylation (H3K27me3), hallmark of gene silencing. Cell type and developmental state-specific PRC2
function largely depends on the dynamic interactome of the complex. PRC2 displays tremendous
compositional complexity, which correlates with pleiotropic roles of PRC2 in cell development. The core PRC2
complex consists of EZH1/2, EED, SUZ12 and RBBP4/7. The mammalian paralogs EZH1 and EZH2 are the
catalytic subunit of PRC2. The enzymatic activity and chromatin targeting of PRC2 are impacted by a diverse
array of accessory subunits, including AEBP2, JARID2, PHF1, MTF2, PHF19 and EPOP, which form two
classes of mutually exclusive PRC2 holo complexes. Besides these mostly dedicated accessory subunits,
PRC2 also dynamically associates with a plethora of other cellular factors to mediate crosstalk with important
cell signaling pathways, for example BRCA1 in DNA damage response and repair, DNMTs in DNA methylation
and genomic imprinting, and CTCF in genome structure and organization.
While biologically and clinically important PRC2 function has been widely appreciated, the underlying
molecular mechanisms are largely lacking. Due to their size and complexity, biochemical reconstitution and
structural analysis of the molecular assemblies of PRC2 present a formidable challenge; only recently have we
and others started to reveal the structural basis of catalysis, chromatin binding and disease mutation of PRC2.
The overarching theme of this MIRA award is focused on the structure and function of PRC2 and aims to
understand how they are regulated to control cell proliferation and differentiation. The proposed study will
close gaps of understanding in the field by addressing the following three specific questions. (1) How the
enzymatic activity of PRC2 is regulated in various cellular contexts? (2) How is PRC2 specifically recruited to
CpG island chromatin? (3) How are the structural mechanisms of PRC2 connected to gene regulation during
some central biological processes, such as stem cell differentiation and epigenetic memory maintenance
during cell division?

Public health relevance
Project Narrative: Polycomb Repressive Complex 2 (PRC2) is a key epigenetic regulator of cell identity maintenance; dysregulation of PRC2 function is linked to human cancers and developmental disorders. PRC2 is recruited to CpG island chromatin to mediate trimethylation of histone H3 lysine 27 (H3K27me3), hallmark for gene silencing. The overall goal of the proposed research is to reveal the structural basis of catalysis and chromatin targeting of PRC2 and to connect the structural mechanisms to PRC2 function in cells.